Soft drusen in rhesus macaques as a nonhuman primate model of early age-related macular degeneration

PROJECT SUMMARY
Age-related macular degeneration (AMD) is the leading cause of vision loss in the elderly, but current treatments
target advanced stages when interventions may be limited by irreversible cell loss. Soft drusen are the initial and
hallmark feature of AMD, but their pathogenesis is unclear and the development of treatments is limited by the
lack of good animal models. Unlike most laboratory animals, nonhuman primates (NHPs) possess a true macula
and spontaneously develop soft drusen resembling early human AMD. Prior studies of NHP drusen have been
observational, cross-sectional, and qualitative, owing to the high costs of maintaining aged animals, limited
longitudinal imaging capabilities, and lack of Next-Generation Sequencing (NGS) and bioinformatics support.
We recently surveyed a unique colony of geriatric rhesus macaques at the California National Primate Research
Center (CNPRC), and found a 30.6% prevalence of drusen. Using high-resolution multimodal in vivo imaging,
we precisely measured drusen progression over 2 years, with histological and ultrastructural correlates
demonstrating lipid accumulation resembling human soft drusen. Similar to cardiovascular diseases, AMD share
epidemiologic risk factors such as high fat diets, susceptibility genes in lipid metabolism, and deposits similar to
atherosclerotic plaques with lipoprotein accumulation, lipid oxidation, and complement-based inflammatory
responses. Recent pilot studies suggest that high-dose oral atorvastatin can cause drusen regression in some
AMD patients, but human studies are limited by the heterogeneity of AMD phenotypes and variability in subject
diets and serum lipid concentrations.
In this study, we plan to establish a new, unique cohort of aged rhesus macaques with soft drusen, and perform
1) detailed ophthalmic characterization using spectral-domain optical coherence tomography (SD-OCT) to
precisely measure retinal layers and track drusen volume, and fundus autofluorescence (FAF) to measure RPE
lipofuscin, 2) metabolic profiling to measure fasting plasma metabolites, lipoproteins, and apolipoproteins, and
3) whole-genome sequencing to identify genetic variants in animals with drusen that may be shared with human
AMD. Next, we will establish the impact of a “Western-style” high-fat/sugar (HFS) diet and high-dose atorvastatin
on drusen progression and RPE health over 2 years, and determine possible correlations with dietary fats and
serum lipids. Finally, we will employ NGS-based single-cell RNA-sequencing (scRNA-Seq) to determine the
gene expression profile in macular RPE cells with and without soft drusen, exposure to HFS diet, or treatment
with high-dose statin, followed by immunohistochemistry of contralateral eyes to evaluate and validate identified
gene sets or pathways, as well as complement and other immune pathways. Together, these studies will not
only establish a highly-valuable and unique cohort of aged rhesus macaques with soft drusen suitable for
translational studies, but also explore the role of dietary lipids, oral statins, RPE gene expression, and immune
pathways in this NHP model of early AMD.

Public health relevance
PROJECT NARRATIVE Drusen are the hallmark feature of early age-related macular degeneration (AMD), but their pathogenesis remains elusive due to the lack of good animal models. Nonhuman primates (NHP) are the only mammals to possess a true macula similar to humans and spontaneously develop soft drusen with lipid accumulation resembling human AMD. This study will establish an NHP model of soft drusen with detailed ophthalmic, metabolic, and genetic characterization, determine the impact of high-fat/sugar (HFS) diet and atorvastatin on drusen progression, and explore the gene expression of macular retinal pigment epithelial cells in eyes with and without drusen, HFS diet, and statins.